Bridges to the Baccalaureate Research Training Program at Cuyahoga Community College

Project Summary/Abstract
Cuyahoga Community College's (Tri-C) application to the National Institutes of Health's
Bridges to the Baccalaureate Research Training Program is being submitted with two
university partners, Case Western Reserve University and Cleveland State University. The
continuing goal of Cuyahoga Community College's Bridges to Success in the Sciences
program is to increase the number of underrepresented students who complete their
science education at the community college level, transfer to and complete their science
education at a four-year institution. Tri-C's Bridges to Success in the Sciences Program
provides academic supports and activities designed to increase the success of
underrepresented minority students studying in biomedical and behavioral science fields.
Bridges will use a cohort model and specific research pathways for our students in the
program. This approach assures continuity of the research experience throughout the
students' participation in the Bridges program. Bridges students will be assigned to
Research Mentors from our partner four-year universities. Over the term of grant, 50
students will work in the lab of the Research Mentor for a minimum of 15 hours a week
during the academic year. Continuing summer research experiences will be available for all
50 Bridges students, working 25-30 hours in the labs of their assigned Research Mentors.
Students entering the Bridges program at Tri-C will be paired with an experienced Tri-C
Bridges Faculty Mentor who will advise the student and carefully monitor his/her academic
progress throughout their tenure in the program. Bridges students, who have transferred to
our four-year partner colleges, will be guided throughout their tenure by University
Pathway Coordinators. Transfer Bridges students at the four-year partner institutions will
also have a guarantee to receive either direct financial assistance through their Research
Mentors or university scholarships after finishing the Tri-C Bridges program and until they
graduate with their baccalaureate degree. In addition to typical course requirements,
Bridges students will be required to complete the developed BIO 1806 Introduction to
Research Methods course and a newly developed CURE (Course-based Undergraduate
Research Experience) class and continue to attend the “Laboratory Techniques and
Practices” seminar series. The seminar series will be integrated into the existing framework
of Bridges workshops, seminars and meetings, which provide additional training for
students and allow for discussion about program operations and additional efforts to better
meet the students' needs.

Public health relevance
Project Narrative The relevance of the Bridges to the Baccalaureate Research Training Program at Cuyahoga Community College is that it increases the number of underrepresented minority students who study in biomedical and behavioral science disciplines. Bridges students advance through the academic pipeline into graduate and postgraduate study and join the scientific research community.